Development of Spectral Phase Contrast Micro-CT

Development of Spectral X-Ray Phase-Contrast Micro-CT
Project Summary
A challenging aspect of in vivo micro-CT relates to the required deleterious radiation dose levels - particularly
for studies required to follow the same subject longitudinally. The main constraint is the poor attenuation
contrast for x-rays in soft tissue and the need for long imaging times. Researchers have studied the use of
multi-energy (or spectral) x-ray acquisitions to perform material decomposition with micro-CT systems, but the
versatility of these methods is again constrained by the same contrast-dose trade-off. Phase-contrast imaging
(PCI) can provide significant phase-enhanced contrast at higher energies, thus potentially reducing micro-CT
dose. However, existing PCI methods still require high dose and long imaging times for accurate phase
retrieval. We have recently developed an algorithmic approach to spectral PCI that enables dose and imaging
times commensurate with attenuation imaging. Our hypothesis is that PCI performed under normal clinical
constraints can yield better tissue quantitation and small feature delineation at lower dose than attenuation
imaging. We shall develop a unique spectral micro-CT system with both PCI and non-PCI capabilities to test
this hypothesis. A key system component will be an innovative high-performance, high-resolution photon-
counting detector (PCD) to be developed jointly under this grant by the University of Houston and Advacam
s.r.o. Two non-interferometric PCI geometries will be evaluated. The first specific aim is to design the micro-
CT system based on considerations such as source kVp and the PCD sensor thickness, pixel size, and energy
bin configuration. PCI-specific criteria include magnification and the x-ray mask properties. Optimization studies
will be carried out for both the PCI and the non-PCI modes. For Aim 2, we will work with Advacam to develop
the wide-area, high frame rate and high Z sensor PCD for the system. The high-performance PCD will be
constructed based on Medipix3RX ASIC technology and will feature high resolution and built-in spectral
correction schemes and fast readouts. Under Aim 3, the micro-CT unit will be constructed and energy
calibration and correction schemes will be developed to allow efficient system performance. Our fourth specific
aim is to compare the performance of the PCI and non-PCI modes of spectral micro-CT with physical phantoms
and animal studies to evaluate the enhancement of low contrast sensitivity. In vivo studies using liposomal
iodine nanoparticles will examine the ability of PCI to distinguish differences in blood vascularity for treatment-
responsive and treatment-resistive prostate cancer models in mice.

Public health relevance
Public Health Relevance Statement The objective of this proposal is to develop a next-generation micro-CT system that offers low-dose, fast x-ray phase-contrast imaging (PCI) for soft tissue imaging. Our proposed system will use cutting-edge high resolution spectral detectors, allowing direct comparison of PCI micro-CT with attenuation-based spectral micro-CT. PCI may provide significant reductions in dose coupled with enhanced contrast and higher fine- structure visibility as advantages for cancer research in animal models.